Internet-Delivered Pain Self-Management to Reduce Pain and Interference in Chronic Pancreatitis

Project Summary
Severe abdominal pain is a cardinal symptom of pancreatitis, present in up to 90% of patients with recurrent
acute pancreatitis (RAP) and chronic pancreatitis (CP). As pain increases in severity and constancy, it is
associated with significant morbidity including depression and anxiety symptoms, low physical functioning,
sleep disturbance, and low quality of life, as well as high economic and societal burden. Painful RAP and CP is
most often managed with chronic opioids, which unfortunately have limited efficacy and substantial risk for
adverse side effects. This application focuses on addressing this treatment gap in pain management with a
well-established nonpharmacologic intervention. Our team has established efficacy of an internet-delivered
cognitive-behavioral therapy (CBT) intervention for chronic pain, and recently adapted it for pancreatitis pain
(the Pancreatitis Pain Course), showing promise for reducing pain and disability in this population. We propose
a hybrid effectiveness-implementation design type 1 trial to make rapid translational gains with the primary goal
of gathering data on CBT treatment effects on pancreatitis pain and pain interference in individuals with RAP
and CP with a secondary goal of gathering implementation data to inform dissemination of the Pancreatitis
Pain Course to real-world settings. Our central hypothesis is that the Pancreatitis Pain Course will be effective
in reducing pain interference and severity in individuals with painful RAP and CP. Our specific aims are to 1)
Determine the effectiveness of the Pancreatitis Pain Course in improving pancreatitis pain outcomes, 2)
(Exploratory) Explore the moderating effects of social determinants of health with changes in pain interference
and severity following treatment, and 3) Identify implementation facilitators, challenges, and solutions for
structures and processes that contribute to the seamless integration of the Pancreatitis Pain Course into
clinical centers and the community. This study will leverage resources of the Chronic Pancreatitis, Diabetes,
and Pancreatic Cancer (CPDPC) Consortium, a NIDDK-sponsored U01 consortium with recruitment from their
nine clinical centers and from self-referral in the community through partnership with the National Pancreas
Foundation. Using a multicenter randomized-controlled pragmatic clinical trial, we will enroll 280 individuals
with painful CP into the clinical trial and randomize them to CBT, providing access to the Pancreatitis Pain
Course to learn pain self-management skills (e.g., relaxation, activity pacing, goal setting) or education control
(access to education website about RAP and CP pain). We will collect patient-reported outcomes at baseline,
two months, and six-month follow-up. Relevant stakeholder groups (patients, providers, organizational
managers) will participate in a process evaluation to inform future implementation in clinic and community
settings. The proposed investigation will significantly advance solutions for nonopioid pain management in CP.
If successful, our project will minimize disparities in care, and address a critical need for low-cost, accessible
pain self-management for individuals with painful CP.

Public health relevance
Project Narrative Severe and disabling abdominal pain is common in individuals with chronic pancreatitis. Although pain is associated with reduced quality of life and high economic and societal costs, there are limited effective options for pain management in this population. This study proposes an evidence-based psychological intervention approach using an internet-delivered cognitive-behavioral program to minimize the impact of pain and improve quality of life. The ultimate goal is to maximize the public health impact of the intervention with successful implementation and dissemination to pancreas clinics and to the community.